Novel approaches to the study of laryngeal muscle in functional voice disorders

PROJECT SUMMARY / ABSTRACT
Vocal muscle hyperfunction, tension, and fatigue are considered ubiquitous to functional voice disorders. Alt-
hough these voice disorders make up a large portion of cases on clinical caseloads in outpatient voice settings,
diagnostic methods and appraisal of treatment approaches lack. This gap has led to a heavy emphasis on ex-
clusionary diagnostics and clinical management steeped in trial and error. The long-term goal of this work is to
address these methodological gaps and improve diagnostic specificity, therapeutic management, and treatment
outcomes in functional voice disorders. As such, the overarching objectives of this proposal are twofold: The first
goal (Aim 1) is to validate a novel method—ultrasound shear wave musculoskeletal elastography (SWE)—for
the study of laryngeal muscle structure and function in patients with functional voice impairments and compare
differences in the laryngeal muscles of individuals without vocal impairments pre- and post-vocal load. SWE
uses acoustic radiation force impulse technology, where the acoustic beam generated by the ultrasound trans-
ducer compresses the underlying tissue and induces a local shear wave; the higher the propagation velocity of
the shear wave, the greater the muscle tension. Quantitative analysis using SWE has been shown to be objec-
tive, reproducible, and can capture heterogeneity within motor units of skeletal muscle in the limbs. The second
goal (Aim 2) is to identify clusters of laryngeal-respiratory clinical profiles in patients with functional voice disor-
ders. This aim will be accomplished using cluster analytic methods of shear wave elastography and laryngo-
scopic ratings of laryngeal muscle structure and function as well as aerodynamic measures of subglottal pres-
sures and transglottal airflow.
A total of 120 participants with (n = 60) and without (n = 60) functional voice impairments—will be enrolled in the
study over the course of 3 years. Shear wave velocities of the hyolaryngeal extrinsic muscles—anterior digastric
and sternohyoid—in patients with and without functional voice impairments will be conducted twice: the first time
before a 1-hour vocally fatiguing task and the second time after vocal load. Shear wave velocities, hyolaryngeal
muscle asymmetries, and intrinsic laryngeal muscle stability (% perturbations) will be calculated and used as
outcome measures. Additionally, aerodynamic measures of subglottal pressures and transglottal airflow and
VALDI ratings of supraglottic compression will be acquired for Aim 2.
Anticipated results are improved methodological tools to study the impact of the laryngeal muscles in voice
disorders and a better theoretical understanding of relationships between the laryngeal muscles and respiratory
system. Outcomes of this proposal will provide a springboard into future investigations to improve mechanisti-
cally-driven diagnostic paradigms and increased precision in therapeutic targets in individuals with functional
voice disorders, thus reducing burdens of illness and disability.

Public health relevance
PROJECT NARRATIVE The lack of well-vetted objective clinical tools for unequivocal diagnosis and management of functional voice disorders has resulted in differential diagnoses based on exclusion and treatment approaches grounded in trial and error. Validated methods to investigate the role of laryngeal muscle tension and hyperfunction in laryngeal- respiratory coupling considered central to functional voice disorders will improve diagnostic specificity, increase precision of therapeutic targets, and reduce financial and resource burdens on the patient and medical system.